CSHL 2023 Genome Informatics Conference

GENOME INFORMATICS
December 6 - 9, 2023
ABSTRACT
The Cold Spring Harbor Laboratory conference on Genome Informatics will focus on the development
and utilization of large-scale genomic data and annotations. Genomic resources provide the fundamental
descriptions of an increasing array of organisms at the molecular level. This meeting forms part of a series that
alternates annually between Cold Spring Harbor, USA and Hinxton, UK. The goal of the series is to explore both
the latest provision of these resources, and perhaps most importantly, their use as engines of biological
discovery. This ranges from the storage of data and their associated data models, to the design of effective
algorithms to uncover non-obvious aspects of these datasets, to ontologies to concisely describe biological
information, and software systems to support curation, visualization, and exploration. The conference also covers
the use of genomics in combination with various imaging applications and the latest attempts to understand
microbial pathogenesis based on genomics. The conference has expanded its remit over the last few years, to
ensure it remains current with the latest applications of informatics, all the while ensuring a strong focus on
biological informatics. The conference brings together some of the leading scientists in this growing field, and
we strongly encourage researchers from other large scale information handling disciplines to attend.

Public health relevance
GENOME INFORMATICS December 6 - 9, 2023 LAY NARRATIVE The explosion of genomic information in the past decade poses an enormous challenge to computational biologists in how to manage this information and render it meaningful and useful. Without intense discussion of a variety of different approaches to handling this information to ensure that it can be applied across diverse species, systems and scales, the data is in danger of being isolated in virtual silos where it is much less useful. The Cold Spring Harbor Laboratory conference on Genome Informatics will focus on the provision and use of large scale genomic data and annotations. Genomic resources provide the fundamental descriptions of an increasing array of organisms at the molecular level. The goal of the series is to explore both the latest provision of these resources, and perhaps most importantly, their use as engines of biological discovery. This ranges from the storage of data and their associated data models, to the design of effective algorithms to uncover non- obvious aspects of these datasets, to ontologies to concisely describe biological information, and software systems to support curation, visualization, and exploration.